Adipocyte lipolysis regulates skin repair

Project Summary
My laboratory recently uncovered an unexpected and intriguing role for mature adipocytes during skin wound
healing: control of inflammation after injury. In particular, we identified that mature adipocytes undergo lipolysis
to release of lipids into wound beds to initiate inflammation. Our findings are important for several reasons. First,
adipocytes have been shown to improve wound healing and scarring yet how mature adipocytes function in this
process is unclear. Second, the release of lipids from adipocytes, or lipolysis, has been shown to modulate
inflammation in traditional depots, yet whether skin adipocytes regulate the essential inflammatory processes
following skin injury is not known. Furthermore, adipocytes and their derivatives (fatty acids and/or cytokines)
are a tractable cell type to create a personalized therapy to promote healing in patients with chronic wounds.
Finally, glucocorticoids are known to influence adipocyte biology and also to inhibit wound healing, but whether
the effect of glucocorticoids on wound healing is mediated through adipocytes is not known. Through three
focused and complementary Specific Aims, the work proposed in this application will take advantage of multiple
genetic mouse models that allow specific depletion of adipocytes, adipocyte lipolysis, lipidomics, lipid tracking,
bioengineered tissue models, and a novel bioanalytical assay platform to define the function adipocyte-derived
lipids during skin injury and how these are altered with glucocorticoids, age, diabetes and obesity. We will (1)
identify the role of adipocyte derived lipids during inflammation during skin wound healing, (2) determine whether
glucocorticoids influence wound healing through depletion of lipids from mature, dermal adipocytes, (3) define
whether adipocyte fatty acids can modulate wound healing in aged and diabetic mice or are altered in human
skin. These studies will identify specific pro-healing cell populations and molecules that can be utilized to
promote healing in human patients with defective wound healing or other skin disorders.

Public health relevance
Project Narrative A thorough understanding of cells and molecules that regulate tissue repair and fibrosis is essential for the generation of tissue-specific regenerative therapies to effectively treat human disease. Since the manner in which adipocytes function during skin wound healing is largely unknown, we will define how these major but poorly understood cells function during skin wound healing. Our work will improve our understanding of the cells and molecules that control basic skin regeneration, how adipocytes function in this process, and will have global relevance for other tissues that contain adipocytes.